ZONISMIDE IN THE TREATMENT OF SEIZURES IN PATIENTS

The purpose of this investigation is to study the efficacy and safety of zonisamide compared to placebo when added to treatment with other seizure medications.